Suppression of Dominant-Negative Transcripts Escaping from Nonsense-Mediated mRNA Decay

Abstract
Nonsense-mediated mRNA decay (NMD) is a cellular RNA surveillance mechanism that plays a
fundamental role in human health and disease. NMD selectively recognizes and degrades
aberrant RNAs such as mutated transcripts and many viral RNAs. NMD misregulation is
associated with disease onset and severity in various neurological disorders, cancers, and
infectious diseases. Therefore, controlling NMD activity is an attractive approach to developing
novel therapeutics for many human diseases.
Although the suppression of NMD by premature termination codon (PTC) read-through
strategies using aminoglycoside antibiotics or suppressor tRNAs has been widely studied, there
are significant limitations to their efficacy and specificity. Conceptually, these PTC read-through
strategies inhibit NMD and produce limited quantities of functional proteins. In contrast, the
concept of NMD induction with the goal of selectively degrading NMD-insensitive targets has
barely been studied. The method of NMD induction is critical for a subset of human diseases
because about one-fourth of disease-causing PTCs are predicted to be insensitive to NMD.
Although most of the NMD-insensitive transcripts are expected to produce truncated proteins and
induce a gain-of-function or dominant-negative effect, the underlying molecular mechanisms are
largely uncharacterized. Thus, there is no target-specific molecular therapy for NMD-insensitive
disorders.
Based on over ten years of experience in molecular studies of NMD mechanisms and using
cutting-edge CRISPR-Cas13 technology, this proposal aims to establish a novel therapeutic
approach, namely, the RNA-Programmed NMD Activation (RP-NMDA) system, to suppress NMD-
insensitive dominant-negative transcripts. Aim 1 is a proof-of-concept experiment to develop the
RP-NMDA methodology to trigger NMD of dominant-negative transcripts using a well-defined
NMD reporter derived from the human beta-globin (HBB) gene. Aim 2 will extend the RP-NMDA
approach to human colorectal cancer cell lines to selectively suppress both the expression of APC
truncations and cancer progression. This application has high promise to specifically degrade
aberrant transcripts derived from a mutated NMD-insensitive allele without any toxic effects on
normal transcripts. If successful, my proposed innovative work will not only provide a disease-
specific and efficient drug for dominant beta-thalassemia and colorectal cancers but also provide a
potential therapeutic strategy for any NMD-insensitive disorders.

Public health relevance
Project Narrative Nonsense-mediated mRNA decay (NMD) is a cellular RNA surveillance mechanism that selectively recognizes and degrades mutated transcripts harboring premature termination codons (PTCs) and many viral RNAs. However, the approach of NMD induction to selectively digest NMD-insensitive dominant-negative transcripts has never been undertaken. This proposal aims to establish a novel therapeutic strategy for NMD-insensitive disorders to suppress the expression of aberrant transcripts.